Decoding mechanisms underlying metabolic dysregulation in obesity and digestive cancer risk

PROJECT SUMMARY/ABSTRACT
Obesity is associated with increased risk of at least 13 cancers. Of all cancers attributable to excess adiposity,
colorectum and liver account for 55% of cancer among men and 48% among women, excluding reproductive
cancers. Although most epidemiologic studies of obesity as a cancer risk factor evaluated body mass index
(BMI), accumulating evidence for colorectal and liver cancers implicates viscerally located adiposity (and its
closely related glycemic metabolic dysregulation) as the likely direct causal component. How visceral adiposity
mechanistically predisposes its proximal organs to cancer is largely unknown. Inflammation undoubtedly plays
a role in development and progression of malignancies, including colorectal and liver cancers; however, the
large body of evidence for general inflammation processes and systemic markers like C-reactive protein (CRP)
in relation to digestive cancers are underwhelming, possibly because most are non-specific to high-risk
metabolically unhealthy obesity per se. Thus, distilling the inflammatory pathways and markers to identify those
most reflective of the metabolically unhealthy obese state has immense potential to uncover key mechanisms
and inform powerful broad-spectrum strategies for prevention. Techniques to obtain precise measures to
characterize metabolically unhealthy obesity are often prohibitively costly and logistically infeasible in the
context of large population-based studies. Therefore, we propose an innovative approach to address these
gaps by (i) deriving novel proteomic-based inflammation signatures of metabolically unhealthy obesity
(“Inflammotypes”) in cohorts with visceral adipose tissue quantified via dual-energy X-ray absorptiometry
(DXA) and traits of glycemic metabolic function; then (ii) prospectively investigating these novel Inflammotypes
in longitudinal cohorts with stored blood samples in relation to incident colorectal and liver cancer risk. We will
characterize Inflammotypes via state-of-the-art Olink proteomic panel (384 inflammation-related proteins) to
describe metabolically unhealthy obesity (i.e., higher visceral adiposity, with homeostatic model assessment
for insulin resistance [HOMA-IR], hemoglobin A1c [HbA1c], or lipoprotein insulin resistance score [LPIR]).
Machine learning analyses to identify the Inflammotypes will be replicated in an external cohort. We will then
investigate the relationship between proteomic Inflammotypes with long-term risk of incident colorectal (1000
cases/1000 controls) and liver cancer (500 cases/500 controls), combining longitudinal cohorts with stored
baseline bloods and long-term follow-up (median ranges 6.1-16.7 years). Based on compelling preliminary
data, we hypothesize the combination of greater visceral adipose tissue and glycemic metabolic dysregulation
are associated with abnormal profiles of circulating proteins, and that these novel Inflammotypes are
independently predictive of long-term colorectal and liver cancer risks. These aims are closely aligned with the
goals of the Metabolic Dysregulation and Cancer Risk Program, including enhancing identification of high-risk
individuals, risk prediction, and elucidation of potential preventive and therapeutic targets.

Public health relevance
PROJECT NARRATIVE Evidence collectively implicates visceral adiposity and its closely related metabolic dysregulation as a causal driver of obesity-related colorectal and liver cancers. Inflammation has been proposed as a mediating factor, but the precise inflammatory pathways that best describe the metabolically unhealthy obese state are unknown, warranting well-phenotyped large prospective cohort studies Thus, novel approaches for distilling the inflammatory pathways and markers to identify those most reflective of the metabolically unhealthy obese state have immense potential to uncover key mechanisms and inform powerful broad-spectrum strategies for preventing these cancers.